Examining Interoceptive Awareness as a Mechanism of Change in Yoga for Chronic Low Back Pain

PROJECT SUMMARY
Chronic pain is a major public health concern and among the most common reasons adults seek medical care in the
United States. Chronic pain is a complex biopsychosocial process modulated by psychological factors, including the
perception, appraisal, and emotional processing of sensations. Chronic low back pain (CLBP) is increasingly common and
is associated with poor physical and mental health. Pharmacological approaches are relatively ineffective for long term
pain treatment and have high addictive and abuse potential. Given the myriad economic, psychological, and social costs
associated with CLBP, mind-body therapies (MBTs) such as yoga have received growing attention and empirical support
for its treatment. Still, less is known about how yoga improves pain outcomes for CLBP or how it compares to and
whether it operates distinctly from other physical activity interventions commonly used to treat CLBP. One hypothesized
mechanism of MBTs for improving chronic pain is through improvements in interoceptive awareness, or the awareness
of one’s internal bodily sensations. To date research has not examined the mechanistic role of interoceptive awareness
in MBTs for CLBP. Thus, building on an ongoing NCCIH-funded randomized controlled trial (RCT) comparing 12-week
yoga and physical activity interventions for CLBP, the proposed predoctoral study aims to 1) test whether a yoga
intervention results in greater changes in interoceptive awareness compared to physical activity; and 2) determine
whether changes in interoceptive awareness account for the clinical benefit of yoga for individuals with CLBP as
assessed by multiple measures of pain. This predoctoral study capitalizes on an ongoing clinical trial and adds a unique
and important contribution by assessing participants’ interoceptive awareness at baseline, mid-treatment (6-weeks),
and post-treatment (12-weeks). The proposed project will test the mechanistic role of interoceptive awareness on
improvements in both self-report (i.e., pain severity and interference) and objective (i.e., pain sensitization) assessments
of chronic pain. This research project will directly address three of NCCIH’s top research priorities by elucidating the
mechanistic role of interoception in mind and body treatments for pain. If the mechanistic role of interoceptive
awareness in yoga is supported, non-pharmacological mind-body pain therapies can be further optimized for enhanced
effectiveness in relieving CLBP. The fellowship’s training aims align closely with the goals for the proposed research
project. The individualized training plan will provide the applicant with specialized training in interoception, RCT
methodology, MBTs, biostatistics, and professional development for a research career in behavioral medicine. The
training plan will leverage existing resources available at the applicant’s primary institution, the University of
Connecticut, with collaboration and mentorship from leading experts across the nation.

Public health relevance
PROJECT NARRTIVE Chronic pain is a leading cause of disability and major public health concern; thus, research aimed at improving our understanding of non-pharmacological approaches to pain management is crucial. Although individuals with chronic pain demonstrate interoceptive deficits, and mind-body therapies (MBTs) are purported to improve chronic pain conditions, limited research has directly examined interoception as a mechanism of change in MBTs. This predoctoral training and research project builds upon an existing program of research to study changes in interoceptive awareness as a mechanism of change in MBTs for chronic low back pain.